In Vivo Measurement of Human Brain Tissue, Blood, and CSF Dynamics Supporting Glymphatic Function

ABSTRACT
Waste clearance in the central nervous system is impaired in many neurological diseases; its dysfunction likely
accelerates the pathological accumulation of misfolded proteins that causes many dementias and hinders the
efficacy of therapeutics designed to remove these proteins. There is a need for therapies that fortify and promote
the brain’s own clearance mechanisms, but many of these mechanisms are still unknown due in part to the lack
of noninvasive tools such as magnetic resonance imaging (MRI) to measure clearance dynamics in individual
patients. Waste clearance in the brain relies on CSF flow, which has been demonstrated in response to arousal
changes, cardiac-driven arterial pulsations, respiration, and neural activity, with hemodynamics often considered
as a driving force. However, it is unknown to what extent the viscoelastic brain tissue motion may also influence
CSF flow, in part because measuring tissue motion requires in vivo measurements and an intact cranium for
unaltered intracranial pressure to observe brain motion in its natural state. Now, there is an opportunity to use
sensitive MRI “motion-encoding” tools to quantify tissue and CSF motion and measure blood dynamics regionally
at the level of a cortical gyrus to investigate how blood and tissue dynamics impact CSF flow.
We propose to develop a novel MRI method to capture hemodynamics, brain tissue displacement, and
CSF flow concurrently and at high spatial resolution, facilitating hypothesis testing of CSF flow mechanisms in
vivo. To capture tissue displacements on the order of tens of microns, we propose to adapt the Displacement
ENcoding with Stimulated Echoes (DENSE) method to our ultra-high magnetic field strength MRI scanner and
extend it to measure hemodynamics concurrently. Our method is novel because blood, tissue, and CSF
dynamics have not yet been measured concurrently in vivo, or at the targeted spatial scale of a cortical gyrus.
We will measure these dynamics during the cardiac cycle and respiration, and in response to neuronal
stimulation driven by a visual stimulation task, as each of these physiological processes are hypothesized to
influence CSF dynamics. Given the concurrent measurement of all compartments, this method may be used in
future studies of spontaneous neural dynamics, such as during sleep. Understanding flow mechanisms of CSF
may reveal opportunities for therapeutic intervention to promote waste clearance in the aging brain.
The applicant’s long-term goal is to lead an academic research team that is focused on applying novel
neuroimaging techniques to critical questions in neurodegenerative disease. The proposed training plan centers
on MRI physics and acquisition, advanced spatiotemporal analysis of neuroimaging data, research design and
experimental methods, the pathophysiology of neurodegenerative disease, and professional development in
science dissemination and leadership. The proposed research plan will take place at the Athinoula A. Martinos
Center for Biomedical Imaging at Massachusetts General Hospital, which is renowned for neuroimaging methods
development and clinical translation and will further support the applicant’s training and career development.

Public health relevance
PROJECT NARRATIVE Healthy brain function requires removal of waste products, which typically occurs naturally, and impairment of this brain clearance is associated with many diseases such as Alzheimer’s disease and other forms of dementia. Our understanding of the function and dysfunction of this clearance process limited, partly due to a lack of tools to observe this process in humans and understand how it fails. Here, we propose a novel Magnetic Resonance Imaging method that can observe aspects of brain clearance and use it to test a hypothesis that clearance is in part driven by dynamic changes in brain blood vessel size and subsequent motion of brain tissue and the surrounding cerebrospinal fluid.